Natural killer cell and T-cell crosstalk in CMV infection

ABSTRACT Human cytomegalovirus (HCMV) is the most common cause of congenital viral infection and an important cause of morbidity and mortality following solid organ and hematopoietic cell transplantation. Understanding how the immune system responds to HCMV is vital to the efforts to achieve efficient eradication of infection. This proposal aims to identify novel relationships between NK cells and T cells during HCMV infection, with the central hypothesis that a strong T cell response to HCMV infection can abrogate the emergence of an NK memory phenotype; reciprocally, a HCMV-activated NK cell can regulate the magnitude of the T-cell response. Using a unique fully autologous in vitro HCMV infection system, regulatory relationships between NK cells and T cells can be investigated and identified. Preliminary studies have generated the novel finding that direct interaction of NK cells with HCMV-infected dendritic cells induces PD-L1 surface expression on NK cells, which directly inhibits antibody-mediated T cell proliferation. To determine the impact of PDL1+ NK cell on HCMV antigen specific T cells, T cell responses to HCMV infection will be stimulated by the use of an artificial antigen-presenting cell pulsed with CMVpp65 peptides. Co-incubation of CMV-activated PDL1+ NK cells and CMV- sensitized T cells will permit elucidation of regulatory effects of one lymphocyte on the other. Additionally, preliminary data from an in vivo murine model has recapitulated findings in the human studies, showing a significant increase in the number of PDL1+ NK cells following MCMV infection of C57BL/6 mice. Using genetically novel murine systems, the in vivo impact of PDL1+ NK cells on MCMV-specific T cell responses and the efficiency of viral clearance will be determined. These murine models will allow for correlation of strength of the NK cell response with CMV-specific T cell responses and will also provide insight to how this relationship is controlled. The understanding of NK and T cell relationships developed in the in vitro and in vivo studies will be applied to the study of expansion and maintenance of adaptive NKG2C+ NK cells in healthy human donors as well as in patients with CMV reactivation following stem cell transplantation. The availability of blood samples from a cohort of hematopoietic cell transplant patients with CMV reactivation provides the unique opportunity to examine the NK and T cell repertoire in the setting of CMV infection. These studies will describe novel mechanisms that will expand existing knowledge on the balance of the adaptive and innate immune systems during viral infection and will provide further insight to mechanisms that can be targeted to prevent reactivation and chronic viral infection.

Public health relevance
PROJECT NARRATIVE The purpose of the proposed study is to determine the relationship between two different types of immune cells and to understand how their relationship impacts the ability of the immune system to efficiently clear common viral infections. This study will focus on the immune response to cytomegalovirus, a common virus that can threaten the lives of newborns and people with weak immune systems. Understanding how the immune cells contribute to the overall immune response is important in the treatment of patients who may become infected with the virus.